Characterization of Persistent COVID-19

PROJECT SUMMARY
Immunosuppressed individuals are increasingly recognized as a focal point of the COVID-19 epidemic. They are
at increased risk of chronic COVID-19 infection, therapeutic treatment failure, severe disease and COVID-19
mortality. Evidence is also emerging that they may also be drivers of COVID-19 variant/subvariant emergence,
due to their risk of prolonged infection and accelerated viral evolution. However, the immune and viral
mechanisms by which chronic infection, viral evolution, and drug resistance occur in this population are poorly
understood. To improve health outcomes for this high-risk population and to reduce the risk of viral evolution and
drug resistance, there is an urgent need to address gaps in our understanding of which immune deficiencies
increase the risk of chronic COVID-19 infection and accelerated viral evolution. The primary goal of this proposal
is to determine the host and virologic characteristics that promote chronic viral infection and viral evolution. The
proposing investigators will an existing translational research infrastructure with experience recruiting cohorts
of immunosuppressed individuals with COVID-19 and broad expertise in clinical research, viral quantification,
viral culture, sequencing, and immunology. The results will provide critical new data about COVID-19
pathogenesis, variant evolution, therapeutic response, and inform the clinical care of immunosuppressed
populations. By deepening our understanding of the immune pathways of viral clearance, the results from this
proposal may also identify potential targets for the next generation of vaccines and therapeutics.

Public health relevance
PROJECT NARRATIVE Immunosuppressed individuals are at increased risk of persistent COVID-19 infection and therapeutic treatment failure, but the mechanisms by which chronic infection, viral evolution, and drug resistance occur in this population are poorly understood. The proposing investigators will leverage an existing translational research infrastructure with experience recruiting cohorts of immunosuppressed individuals with COVID-19 and broad expertise in clinical research, viral quantification, viral culture, sequencing and immunology. The primary goal of this proposal is to determine the host and virologic characteristics that promote chronic viral infection, and the results will provide critical new data about COVID-19 pathogenesis, variant evolution, therapeutic response, and inform the clinical care of immunosuppressed populations.